HIV CO-INFECTIONS IN UGANDA

Increasing availability of antiretroviral therapy (ART) in sub-Saharan Africa (SSA) has led to
decreases in mortality rates. The WHO estimates that 940,000 million deaths were attributable
to HIV in 2017, with the majority caused by co-infecting pathogens.
Uganda still has a prevalence rate of 6.5% among adults aged 15-49 (UNAIDS). Many patients
still present late and often co-infected with opportunistic infections such as tuberculosis (TB)
and cryptococcal meningitis. Viral hepatitis (B & C) co-infection occurs in 2-10% and poses
challenges in terms of best anti-viral treatment, diagnosis, and prevention. Challenges present
also for HIV-infected individuals stable on ART, because they are at higher risk of “non AIDS”
non-communicable diseases, particularly hypertension, diabetes mellitus, renal disease,
pulmonary disease, cardiovascular disease, cancer, bone abnormalities and liver failure. HIV
infection itself also seems to be associated to an accelerated aging process.
The Infectious Diseases Institute (IDI) in Uganda is a Research and Care Center of
Excellence and has already established research programs in HIV and co-infections under
the previous Heads of Research (Y. Manabe, and A Kambugu, previous Program Director
and Uganda Program Director respectively). The current Head of Research (B Castelnuovo-
proposed Program Director in this Cycle), has worked closely with Dr Manabe and Dr
Kambugu for the last 10 years, when she was the Head of the Research Capacity Building
Unit and Deputy Head of Research.
We plan to train 9 master students, 2 PhD students and 5 post-doctoral students at Makerere
University, Uganda. Our previous 5-year cycle has solidified a core group of productive,
independent scientists through post-doctoral training who can now act as local mentors. We
will shift the leadership of the training program from the US to the Uganda Institution in order
to ensure sustainable research capacity building. We will also encourage a peer-to-peer
mentorship model among scientists with the same level of experience to expand the impact
of training. International mentors will still play a key role in overall mentorship of the local
experts particularly to expand research networks and to provide grant-writing support.
At the end of this 5-year training program, our overarching objective is to solidify a core group
of expert, productive, independent scientists who can promote sustainable capacity building
by garnering outside funding, continuing to mentor others including peers, and be recognized
as international, regional leaders and mentors in the area of HIV co-infections.

Public health relevance
Project Narrative The proposed continuation of the partnership training program for the Johns Hopkins University Bloomberg School of Public Health in Baltimore and the Infectious Diseases Institute (IDI) in Uganda will train Post-Doctoral Fellows, PhD, and Masters Students, who will be mentored by a pool of dedicated local mentors, guided by an international faculty who have previously engaged in funded, regionally relevant, published research in HIV and co-infections (tuberculosis, cryptococcal meningitis, viral hepatitis, and long term complication). At the end of this 5-year training program, our overarching objective is to solidify a core group of productive local mentors, who in turn can train scholars in garnering outside funding, mentoring others, and being recognized as regional, international, leaders who are able to influence policy and practice in the area of HIV and co-infections